PHARMACOKINETICS OF TERAZOSIN AND VERAPAMIL IN TREATMENT OF HYPERTENSION

The purpose of this study is to evaluate the safety and efficacy of Terazosin and Verapamil administration and the interactions between the two drugs in patients with essential hypertension.